EFFECTS OF HUMAN PTHRP (1-36) INJECTION ON MINERAL HOMEOSTASIS

This study was a Core Lab only protocol. A collaborative arrangement was made with the GCRC Core Lab and the GCRC at Yale to perform these assays for one of their protocols.